Biorepository and Central Laboratory Core

PROJECT SUMMARY: CORE C (MILWAUKEE)
Core C contains the central specimen management site and accompanying database, the central laboratory for
sample testing, and serves as the coordinating IRB. The Core C PI, Dr. Veronica Flood, and the lead clinical
research coordinator, Pam Christopherson, have extensive experience in sample management and VWF
assays. Core C will facilitate the acquisition of additional samples, maintain the biorepository, assure the
integrity and confidentiality of the database, and maintain IRB approval. Core C will also handle shipment of
samples to other investigators as needed. The significance of this core is to continue a longitudinal cohort of
samples that will enable serial VWF evaluation over time, and help explain the biology of VWF in terms of its
genetics, regulation, clearance, and glycosylation. This is critical to improving our understanding of VWF and
aging, the cause of increased VWF with age, and the impact of increased VWF with age on hemostasis and
thrombosis.